DF/HCC Prostate SPORE

PROJECT SUMMARY – ADMINISTRATIVE CORE (CORE A)
The DF/HCC Prostate SPORE Administrative Core (Core A) is instrumental for the overall function and
success of the Prostate SPORE program. The Directors will work closely with Advisory Board Members,
Patient Advocates, and SPORE investigators to foster an environment that promotes collaboration and
transparency in research. Regular reviews and fiscal oversight by Core A will ensure that the program has the
resources it needs to be successful. Core A will also ensure that the SPORE integrates well with the broader
DF/HCC program and is capable of leveraging resources and institutional infrastructure to accelerate
translational prostate cancer research. The Administration Core’s Specific Aims are: 1) to provide resources
and fiscal oversight; 2) to monitor research progress and plan for the future; 3) to integrate the SPORE within
the Dana Farber/Harvard Cancer Center; 4) to foster collaborative research and dissemination of research
findings; and 5) to integrate a patient perspective throughout all research activities in the Prostate SPORE.